Reformulating NT-Z001 and its delivery route to treat rheumatoid arthritis

PROJECT ABSRACT
A significant proportion of rheumatoid arthritis (RA) patients—30-70%—continue to report pain despite
treatment with disease-modifying antirheumatic drugs (DMARDs). This persistent pain may be attributed to
incomplete inflammation control, post-inflammatory or neuropathic conditions, or mechanisms such as central
sensitization. The objective of this SBIR transition grant is to reformulate NT-Z001, an epigenetic gene
therapy, to better address the needs of RA patients by enabling localized joint injections instead of the more
invasive intrathecal (IT) route. NT-Z001 targets the NaV1.7 sodium channel, a key mediator of pain, offering
a novel approach to chronic pain management that could reduce reliance on opioids and other analgesics.
By downregulating NaV1.7 expression through AI-designed zinc finger (ZF) proteins fused to a repressor
domain, NT-Z001 aims to provide durable pain relief and address inflammation, macrophage infiltration, nerve
sprouting, and joint remodeling in RA. NT-Z001's mechanism of action directly interferes with the pain
transmission process, offering a targeted alternative that could significantly improve patient quality of life.
Preliminary studies have demonstrated NT-Z001's ability to alleviate pain and inflammation in preclinical
models mimicking RA pathology. These studies highlight NT-Z001's potential to modulate pain and
inflammatory pathways and, importantly, to reduce peripheral nerve sprouting, which contributes to chronic
pain in RA. This proposal outlines a plan to reformulate NT-Z001 for intra-articular delivery, evaluating viral
(AAV and HSV) approaches to ensure effective localization in the dorsal root ganglia (DRG) after joint
injections. The best-performing formulation will be tested in the collagen-induced arthritis (CIA) model of RA,
assessing its impact on mechanical allodynia, inflammation, and joint pathology. If successful, this work will
enhance NT-Z001's therapeutic potential by offering RA patients a less invasive and more effective option for
pain management. Additionally, it could open the door to developing therapies for other chronic pain
conditions where intrathecal administration is not a suitable approach.

Public health relevance
PROJECT NARRATIVE Many rheumatoid arthritis (RA) patients continue to suffer from chronic pain despite existing treatments, often due to lingering inflammation or nerve-related issues. This project aims to reformulate NT-Z001, a cutting- edge gene therapy, for less invasive joint injections, targeting a key pain pathway to provide long-lasting relief without relying on opioids. Early studies show promise in reducing pain, inflammation, and nerve changes, and the new approach could improve treatment options for RA and other chronic pain conditions.